PHARMACOKINETIC STUDY OF TAXOL &CARBOPLATIN WITH FILGRASTIM IN LUNG CARCINOMA

The objective of this phase I/II study is to determine the maximum tolerated dose of taxol in combination with carboplatin in previously untreated patients with advanced or recurrent non-small cell lung cancer (NSCLC); define the pharmacokinetics of carboplatin with combination therapy and correlate 24 hour total plasma platinum concentration and pharmacodynamic consequences of therapy with carboplatin area under the concentration curve.